Comparing Two Federal Financing Strategies on Treatment Penetration and Sustainment

PROJECT SUMMARY/ABSTRACT
Sustained, widespread availability of evidence-based practices (EBPs) is essential to addressing the public
health and societal impacts of adolescent substance use disorders (SUD), as recognized by the NIDA priority
(Strategic Objective 3.4) to investigate strategies for effective and sustainable implementation of EBPs. There
remains a particularly significant need to identify effective financing strategies, which secure and direct
financial resources to support essential activities for EBP implementation and sustainment, and overcome
cost-related barriers to the availability of effective adolescent SUD treatments. The proposed R01 project will
compare the effects of two SAMHSA grant mechanisms (i.e., financing strategies), which supported the
adoption of an EBP for adolescent SUD, the Adolescent Community Reinforcement Approach, through either
organization-focused or state-focused granting of funds. The Exploration-Preparation-Implementation-
Sustainment framework will guide our study aims, hypotheses, and selection of measures. The interdisciplinary
project team – consisting of experts in implementation science, adolescent SUD treatment, health economics,
public policy, and statistics – will employ a longitudinal, mixed method (i.e., quantitative surveys and qualitative
interviews, document review, and focus groups), quasi-experimental design to compare the grant types’
outcomes and examine theoretically-informed mediators and moderators. Aim 1 will examine penetration of the
Adolescent Community Reinforcement Approach among eligible clinicians (i.e., proportion certified with
adequate fidelity) and clients (i.e., proportion receiving the treatment) at the end of SAMHSA funding; and Aim
2 will examine sustainment of the treatment model, using a 10-element composite measure of treatment
delivery and supervision activities, up to 5 years post-funding. Our approach aligns with a previous grant
(R01AA021217), enabling integration of the data we collect from state-focused grant recipients (85
organizations in 19 states) with previously collected data on implementation and sustainment outcomes among
organization-focused grant recipients (84 organizations in 26 states). We will also evaluate non-equivalent
dependent variables (i.e., outcomes that are not expected to change as a result of grant type) to control for key
observable, time-varying cohort effects within our quasi-experimental study design. Finally, Aim 3 will use
comparative case study methods to identify policy implications for promoting EBP penetration and
sustainability through integration of our diverse quantitative and qualitative measures. The proposed research
will have immediate, practical implications for behavioral health administrators, policymakers, implementation
experts, and the public with new knowledge that can directly inform financing strategies to support large-scale,
sustained EBP delivery in behavioral health – while simultaneously advancing the emergent implementation
science field through use of novel methods to study financing strategies and sustainment outcomes.

Public health relevance
PROJECT NARRATIVE Effective strategies are needed that can secure and direct financial resources to support the adoption of evidence-based practices in adolescent substance use treatment services. The proposed research aims to compare two grant-making strategies used by the U.S. Substance Abuse and Mental Health Services Administration on the widespread adoption and sustained use of one such evidence-based practice, the Adolescent Community Reinforcement Approach, over the past 13+ years. Results will provide critically needed information about the effects of different grant-making strategies in supporting widespread and long- term availability of evidence-based practices, which is necessary to achieving large-scale reductions in adolescent substance use disorders and their major associated public health and societal impacts.